Proximal Determinants of Nephritogenic Autoimmunity

Autoimmunity is the antecedent to most glomerulonephritis, the most common cause of end stage renal disease worldwide. Yet rudimentary understanding of etiology compels reliance on non-specific toxic immunosuppressive therapy. We developed Ig transgenic (Tg) mice bearing B cells reactive with nephritogenic antigens (Ag) as tools to dissect mechanisms controlling humoral autoimmunity that destroys kidney. We postulate that: a) B cells reactive with structurally diverse self-Ag relevant to renal injury are regulated by diverse mechanisms; b) There are differences in molecular pathways maintaining B cell tolerance to nephritogenic Ag in autoimmune vs nonautoimmune individuals, and between individuals bearing different constellations of susceptibility genes; and, c) There are fundamental differences in regulation of B cells that promote nephritis in systemic versus organ-restricted disease. This predicts that different regulatory mechanisms are breached in different autoimmune nephritides. We will use Ig Tg models to pursue the following Specific Aims: 1) Determine the role of deletion and anergy in regulating B cells reactive with basement membrane, the only confirmed target in human autoimmune nephritis. Cell fate will be linked to Ag specificity using anti-laminin LamH/LamL and duat specific LamH/VSR "monoclonal" H+L Ig Tg mice in which collateral regulatory influences are eliminated by inactivated Rag or endogenous Ig genes. 2) Dissect the molecular basis of genetic modification of B cell tolerance. Microarray will be used to monitor and analyze transcriptional profiles in receptor-stimulated tolerant Tg cells from autoimmune MRL and non- susceptible B6 mice to reveal central regulatory pathways. The LamH Tg, with a well defined tolerance phenotype, will also be established on nephritis-prone (NZBxNZW)F1 and BXSB strains to determine if a single Ag-receptor interaction is differentially tolerogenic in genetically disparate disease-susceptible hosts. 3) Determine and compare the fate of kidney-reactive 238H Ig and anti-alpha3(IV) NC1 collagen Tg B cells associated with nephritis in systemic versus renal-limited autoimmunity, respectively. This will assess contributions of nucleic acid crossreactivity and Ag sequestration, factors known to impact immune deposition, to regulation of nephritogenic B cells. Collectively these studies will identify regulatory pathways to be targeted for tailored pharmacologic intervention in immunologic renal disease.